Origins of Cell Geometry

PROJECT SUMMARY/ABSTRACT
The proposed supplemental activities are within the scope of the parent grant, no changes.

Public health relevance
PROJECT NARRATIVE The proposed supplemental activities are within the scope of the parent grant, no changes.